Multimodality PET/CT Scanner for Small Animal Imaging

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to secure funding for an instrument dedicated to in vivo imaging of small animal
models of human diseases via integrated positron emission tomography (PET)/X-ray computed tomography
(CT). The instrument we propose is the GNEXT PET/CT system manufactured by Sofie Biosciences Inc. The
PET component offers a high-resolution, high-sensitivity, and versatile platform for small-animal molecular
imaging. The CT component is a fast, high-resolution system that enables sequential scanning for anatomy
alongside molecular imaging by PET. This system will replace obsolete, stand-alone PET and CT scanners
which are no longer supported by the manufacturer and for which certain key components are no longer
available. The lack of support for these existing scanners is a major vulnerability for a wide range of preclinical
imaging research at our institution. The PET/CT scanner will be installed at the UC Davis Center for Molecular
and Genomic Imaging (CMGI), which is a campus-designated and supported core facility providing infrastructure
and expertise to conduct in vivo imaging studies in small-animal models. CMGI oversees a cyclotron and
radiochemistry facilities dedicated to preclinical imaging research and provides a wide range of tracers and
radioligands that will be available to use with the proposed scanner. Institutional support provided to the CMGI
ensures its successful operation and maintenance for its lifetime. The instrument will support at least 11 major
and minor users who are conducting NIH-funded research in diverse areas such as neurology, oncology,
rheumatology, orthopaedics, nanotechnology and biomedical engineering.

Public health relevance
PROJECT NARRATIVE Sofie Biosciences’ GNEXT scanner for performing small-animal in vivo imaging via positron emission tomography/computed tomography will enhance the scientific rigor and reproducibility of preclinical imaging studies conducted by users of the UC Davis Center for Molecular and Genomic Imaging, utilizing NIH funding. Diverse areas such as neurology, oncology, rheumatology, orthopaedics, nanotechnology and biomedical engineering stand to directly benefit from the unique capabilities of the scanner and the plethora of invaluable correlative data it will produce regarding disease initiation, pathogenesis and response to therapy.